Virginia Accountable Health Equity and Action Dashboard (VA-AHEAD): Community Framing of Equity Data to Support Clinical and Translational Science

VIRGINIA ACCOUNTABLE HEALTH EQUITY AND ACTION DASHBOARD: COMMUNITY FRAMING OF
EQUITY DATA TO SUPPORT CLINICAL TRANSLATIONAL SCIENCE
PROJECT SUMMARY
Disease burden, healthcare delivery, health outcomes, and life expectancy differ strikingly across US
populations and communities. Inequity is deeply rooted in the US healthcare system, and translational science
should study and address the structural biases that lead to disparities. To set priorities and focus research
where needed, translational science teams and communities need to co-create data systems that allow them
to identify health inequities and potential underlying causes; track trends, including the impact of their work;
and collaborate to develop priorities and solutions. The Wright Regional CCTS is a national leader at
developing census tract measures to inform research, training, care, and policy. Our CTSA hub has developed
the HealthLandscape Virginia geospatial and analytic data warehouse with novel community-level metrics that
span workforce, clinical care, community characteristics, social and economic factors, and health outcomes.
We have used HealthLandscape and a novel bright spot and community asset mapping analysis, a blend of
advanced analytics and community engagement, to identify communities that do better or worse than predicted
for opioid overdose deaths and potential causal factors. This approach needs to be expanded to a wider range
of equity issues. Building on existing data, analytics, strengths in community engagement, and HLVA platform,
we propose to develop the Virginia Accountable Health Equity and Action Dashboard (Va-AHEAD). Our work
will occur in four phases: (1) prioritize and co-create with the community new equity goals and measures, (2)
identify bright spot communities that do better than expected and factors that may contribute to their success,
(3) develop shared meaning, products, and action from the data, and (4) disseminate and support use of equity
content. To develop content, we will use unique person-level data (All-Payer Claims Database, state mortality
data), community-level data sources, and authentic community engagement grounded in community-based
participatory research and guided by our bright spot and community asset mapping approach. Content will be
configured in Va-AHEAD. For each equity topic, one of seven existing community advisory boards will support
content development and usability design of content. We will form a new Equity Research Opportunity lab, a
learning community to support use of the dashboard and products for equity research. Milestones to
demonstrate success include: (1) engage community partners to prioritize and coproduce content, (2) calculate
new equity measures, (3) identify bright and cold spot communities and their equity solutions and needs, (4)
engage researchers, learners, care team members, and policymakers to use the dashboard, and (5)
longitudinally track Va-AHEAD use and impact on translational science and equity outcomes. These efforts will
address a longstanding translational science need—new data and analytics for health equity research
determined by the communities that are experiencing inequities. The lessons and infrastructure emanating
from this project will produce a sustainable model that is scalable across the CTSA consortium.

Public health relevance
PROJECT NARRATIVE Clinical translational science could better address health equity if researchers and communities had access to community level data to identify inequities, recognize the people and communities impacted, detect potential underlying causes of and solutions to address disparities, and longitudinally track changes over time. Building on its expertise calculating census tract level community measures, engaging communities to understand needs and priorities, and unique bright spot and community asset mapping approach, the Wright Regional CCTS will develop the Virginia Accountable Health Equity and Action Dashboard (Va-AHEAD) to identify bright and cold spot communities that do better or worse than predicted for 15 equity topics and the modifiable socioecological factors that contribute to outcomes. Once created, we will engage local translational science researchers, learners, care team members, and policymakers to use Va-AHEAD and its community designed products to inform their work, and we will track the use and impact of content on health equity, including the dissemination of the approaches and assets used by bright spot communities for success.